A New Paradigm for Treating Functional Abdominal Pain Disorders in Children

Project Abstract
John M. Hollier, MD, a board-certified pediatric gastroenterologist, is an Assistant Professor at Baylor College
of Medicine who seeks to obtain essential skills and mentored research experience for an independent career
as a pediatric clinical researcher utilizing health technologies. Many health outcomes are affected by poor
medication adherence, ill-advised health behaviors, and poor access to medical care. The candidate’s career
goal is to conquer these barriers by harnessing the potential of current (e.g., mobile) and future technologies
as tools to fulfill these endeavors. Functional abdominal pain disorders (FAPDs) affect up to 15% of school-
age children (and adults) worldwide and are associated with significant morbidity and healthcare costs. Up
to 60% of children with FAPDs go on to have similar conditions as adults. Many affected children suffer from
psychosocial distress like anxiety and depression. The most effective treatment for these disorders
(psychological interventions) remains out of reach for most children with FAPDs. The applicant proposes to
refine his innovative mobile application (App) prototype designed to remotely deliver audio-recorded guided
imagery therapy (ARGIT App) for pediatric patients with FAPDs using accepted technology development
techniques. The applicant has employed a user-centered design approach with patients and providers to
develop a refined ARGIT App (Specific Aim 1). This extension will focus on the grant’s final two Specific
Aims: 2) Conduct a randomized, waitlist-controlled trial comparing treatment with guided imagery therapy
(GIT) versus usual care in children with FAPDs. The GIT sessions will be delivered remotely via the refined
ARGIT App over eight weeks. 3) Assess the acceptability of the refined ARGIT App among affected children
and their caregivers through qualitative interviews. Dr. Hollier has assembled a multidisciplinary team of
esteemed NIH-funded mentors and collaborators with diverse expertise in mobile health App development,
clinical trial methodology, qualitative research methods, and health behavior change specialists. In addition,
the candidate will acquire additional training through workshops and conferences to increase his knowledge
base of chronic pain, community-based participatory research, non-pharmacological technology-based
therapeutics for pain, and professional development supporting grant writing and research team
management. The scientific training and educational opportunities afforded by this grant will lead to
publications, scientific data, and experience that will enhance the candidate’s fund of knowledge for securing
independent NIH funding as a physician-scientist specializing in health technologies.

Public health relevance
PROJECT NARRATIVE Functional abdominal pain disorders (FAPDs) often are associated with significant morbidity, including psychosocial distress and poor health-related quality of life, affect as many as 20% of school-age children and adolescents worldwide, and often are not adequately treated with effective psychosocial therapies, in part, due to lack of access. This proposal aims to develop a mobile application that remotely delivers guided imagery therapy sessions, an effective psychosocial therapy for FAPDs, informed by affected children, their caregivers, and medical and psychological experts and then test its efficacy in a clinical trial. The results of this study will lead to a novel clinical tool that should increase access to a highly effective therapy for pediatric patients with FAPDs.